Validation of a survey tool to evaluate patient-reported outcomes for new medications to treat methamphetamine use disorder: The PROMT Survey

PROJECT SUMMARY
Methamphetamine use is increasing rapidly across the country, paralleled closely by severe addiction- and
health-related outcomes. Behavioral treatment interventions for methamphetamine use disorder (MUD) are
available, but treatment utilization is low and dropout is high. While medication treatment for opioid use
disorder has made substantial progress, there is currently no approved medication treatment for MUD.
A high-affinity methamphetamine antibody medication (IXT-m200) is in development for treatment of MUD,
with a Phase III clinical trial planned for the near future. Given that abstinence is extremely difficult for these
patients, patient-reported outcomes (PRO) must be considered alongside conventional clinical metrics such as
reported drug use and urine drug screens. Defining endpoints for use in future treatment studies that assess
improvement in functioning beyond abstinence, as has been done with opioids, would create opportunities for
new medicines to be evaluated and approved that might not be otherwise. Both NIDA and the FDA have
expressed support for a broad range of practicable endpoints for treatment medication drug trials. Evaluating
new medications using PRO may also spur development of new products that address a fuller range of the
symptoms of addiction.
No validated instrument exists to assess PRO outcomes for new methamphetamine-specific therapies. Better
understanding such endpoints may inform the development of more tailored treatment interventions for a
population historically hard to reach and unlikely to initiate or complete treatment. The proposed study will
develop and validate a PRO survey intended for use in evaluations of medications to treat MUD (PROMT,
Patient-Reported Outcomes for Methamphetamine Treatment). We will develop a conceptual framework to
inform a first PROMT draft, review the content of PROMT with key stakeholders and people who use
methamphetamine through qualitative interviews, and evaluate the psychometric properties of the survey items
through statistical analysis. Importantly, as our study population is difficult to reach and often stigmatized, we
will collaborate with community partners to assist with interview and pilot survey recruitment, including the
Central Arkansas Harm Reduction Project (Little Rock, Arkansas), KC CARE Health Center (Kansas City,
Missouri), and CAPTUS Clinical (Dallas, Texas). A multi-partner, multi-state study design will be critical in
meeting recruitment goals and will maximize the generalizability of PROMT to the US treatment population.

Public health relevance
PROJECT NARRATIVE New medications are being developed for methamphetamine use disorder (MUD) treatment at a time when treatment options are scant and dropout is high, but clinical trials evaluating new MUD medications are currently limited by only assessing abstinence or urine drug screens as endpoints. Both NIDA and the FDA have recognized abstinence as a high bar for MUD treatment, demonstrating an unmet need for a survey of patient-reported outcomes (PRO) that would expand options for measurable endpoints to address how a patient feels and functions. Since no validated PRO instrument for MUD treatment exists, the proposed study will develop and validate a PRO survey (PROMT, Patient-Reported Outcomes for Methamphetamine Treatment) intended to capture a fuller picture of the therapeutic benefits of medications for MUD and promote the continued development of new treatment products.